CORONARY HEART DISEASE AND LDL SUSCEPTIBILITY TO OXIDATION IN MAN

The project will attempt to confirm reports that LDL from men with premature coronary heart disease may be more susceptible to in vitro oxidation compared to men without CHD; study whether differences in LDL composition, subspecies, distribution or antioxidant content explain this later susceptibility of LDL to in vitro oxidation.